Addressing Perinatal Depression and PMTCT Adherence in Malawi: A Couple-based Approach

Project Summary/Abstract
Prevention of mother-to-child transmission (PMTCT) of HIV virtually eliminates transmission of HIV from
mothers to their infants. However, adherence to PMTCT (i.e., adherence to antiretroviral therapy, infant
prophylaxis, and exclusive breastfeeding) during pregnancy and the postpartum period is challenging, with
evidence from sub-Saharan Africa (SSA) showing suboptimal adherence and persistent viremia among
perinatal women. As a consequence, rates of vertical HIV transmission remain unacceptably high. Perinatal
depression is a major driver of women’s poor adherence to PMTCT. Interventions that involve male partners to
provide social and food/economic support could be a promising approach for addressing perinatal depression
and PMTCT, yet few interventions have intervened with couples to improve systems of support,
communication, and other dyadic processes. We propose to develop and test a couple-based approach to
intervene on the mother’s perinatal depressive symptoms and to strengthen the relationship and support
system for partners to work together around depression to improve PMTCT adherence. The study will take
place in antenatal and HIV care settings in Zomba, Malawi. The specific aims are: (1) to develop a couple-
based intervention to target perinatal depression based on an evidence-based approach using problem-solving
therapy (PST), augmented with content on couple communication and problem-solving skills; and (2) to assess
the feasibility and acceptability (F&A) of the intervention via a pilot randomized controlled trial (RCT). For Aim
1, we will use the ADAPT-ITT framework to develop the intervention manual, study procedures, and data
collection instruments and conduct 5 focus group discussions with the target population of couples and key
stakeholders to obtain feedback on the intervention content and materials. For Aim 2, we will recruit 60
pregnant women living with HIV with a positive screen for depressive symptoms and their male partners from
antenatal/HIV clinics. Couples will be randomized to the intervention or a standard of care control (30 couples
per arm) and followed for 3 months postpartum. Primary outcomes will focus on feasibility and acceptability
metrics (e.g., enrollment rates, satisfaction levels, retention, and participation rates). Exploratory analyses will
examine preliminary effects on the mother’s perinatal depression symptoms, adherence to PMTCT, food
insecurity, and mediating variables such as couple communication. We will also examine whether effects on
social support and the mother’s depression are attenuated for couples in which both partners have depression
at baseline. In a subset of 15 couples, we will conduct exit interviews to contextualize F&A data, and will
analyze the mixed-methods data to refine the intervention for a full RCT. Our short-term goal is the produce a
couple-focused PST intervention that can be added to the global health toolkit for treating depression in
perinatal women. Our long-term goal is to produce a high-impact and sustainable intervention leveraging the
couple relationship that can be scaled-up to address depression, PMTCT adherence, and family health.

Public health relevance
Project Narrative This project aims to develop and test a perinatal depression intervention using a couple-based approach that involves male partners to provide social support for depression and to prevent transmission of HIV to infants. Our goal is to demonstrate a proof-of-concept for the proposed intervention, which if shown to be feasible and acceptable, may have the potential to reduce depressive symptoms and ultimately, improve adherence to prevention-of-mother-to-child transmission of HIV outcomes for mothers and infants in sub-Saharan Africa.